IVIG THERAPY FOR THROMBOCYTOPENIA IN PATIENTS WITH HIV INFECTION

The purpose of this research project is to determine the effectiveness of intravenous immunoglobulin in treating chronic idiopathic thrombocytopenia (low platelets) in patients who are HIV positive.